3D-printed Skin and Bone Integrated Pylon (SBIP-3D) for Direct Skeletal Attachment of Limb Prostheses.

Research efforts of the Poly-Orth International demonstrated feasibility of the novel
“Residuum-Integration Prosthetic Technology" to be used in direct skeletal attachment of
limb prosthetics. The technology includes a “Skin and Bone Integrated Pylon” (SBIP),
which connects the residuum with external limb prosthesis and can be especially
beneficial for patients who can not use traditional socket attachment of the prostheses.
As histopathology analysis after the study with small and large animals has
demonstrated, the SBIP is integrated not only with the residual bone, but also with the
residuum’s skin minimizing the risk of infection and secondary trauma. The investigators
developed an optimal porous titanium matrix and design of the Skin and Bone Integrated
Pylon developed with 3D-printing technology to maximize the ingrowth of bone and skin
cells of the residuum to the SBIP without compromising strength of the implanted
device. The technological study on the process of manufacturing of the composite
porous structure enforced with a permeable internal frame.
During the proposed translational pre-clinical study, the animal trials will be
conducted according to the FDA requirements to ensure smooth translation to the trials
in humans. It will include large animals (pigs) and the implantation period up to
30months.

Public health relevance
Inadequate prosthetic rehabilitation after limb amputation is a serious problem relevant to public health. The public value of solving this serious problem is much more elevated when a country is at war. Providing US amputees with infection-safe and long-lasting direct skeletal attachment of prostheses will improve the quality of their lives and eliminate the costs associated with the multiple fabrications adjustments and frequent failures of the prosthetic sockets.